Bioinformatics Core

Project Summary
The PDTC Bioinformatics Core is a key integration point of the PDTC, and will provide the expertise to not
only interpret complex omics data that is already associated with each of our PDX and organoid models, but also
the expertise to identify molecular features of tumors that positively or negatively correlate with drug responses.
The goals of the PDTC Bioinformatics Core are:
1. Provide a major point of integration between Research Projects, since the Bioinformatics Core will
be applying complementary analyses to data from both Research Projects for cross-comparison.
2. To provide statistical modeling for experimental design, particularly with respect to animal
preclinical trials and their analyses, for both Research Projects and Pilot Projects in conjunction with
the two existing institutional cores at HCI and BCM.
3. To import data from institutional core facilities (e.g. standard omics data/pipelines) and directly from
Research Projects and the PDTC PDX Core (e.g. drug response data), as well as from public data
repositories, in order to perform analysis of omics and drug response data.
4. To maximize use of support from the two existing institutional cores at HCI and BCM in support of
work with patient-derived models, including software and database development.
5. To continue to develop novel approaches for experimental design and analytics that can be
implemented at HCI and BCM, and across the PDXNet.
6. To facilitate data organization and exchange between HCI and BCM, and across the PDXNet via
the PDX Data Commons and Coordinating Center.
7. To collaborate in research projects’ data analysis, interpretation of results, and the writing of final
study reports and manuscripts.